SUPPLEMENT FOR A RESOURCE FOR MR AND OPTICAL IMAGING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this supplement is to 1) accelerate the tempo of the core research and its clinical translation proposed under the parent grant by recruiting additional research personnel and 2) to translate the technologies developed under core research at low fields to scanner operating at 7 Tesla field and to exploit the high signal to noise ratio and other high field advantages to benefit ongoing collaborative and service projects. Specifically, optimize all the pulse sequences developed under the core at 1.5 Telsa and 3 Tesla to function at 7 Tesla. This includes optimizing imaging parameters and radiofrequency coils that are required.